Disseminating a Patient Centered Venous Thromboembolism Prevention Bundle

Summary
Venous thromboembolism (VTE) has been called the single leading cause of preventable harm in
hospitalized patients by AHRQ. Numerous studies have focused on improving prescription of VTE prophylaxis
medication for hospitalized patients; however, prescription does not ensure administration. We found that VTE
prophylaxis medication nonadherence among hospitalize patients is highly prevalent; on some floors patients
miss only 5% of doses and on others nearly 40%. The most frequently documented reason for non-
administration is patient refusal. Among patients with preventable VTE (defined as VTE in patients not
receiving prophylaxis), the majority (72%) were prescribed optimal prophylaxis but missed one or more doses.
Classically, interventions targeting medication nonadherence have been focused exclusively on outpatient
settings, limiting their generalizability to hospitalized patients. In 2013, we were funded by the Patient Centered
Outcomes Research Institute (PCORI) to develop and deliver a patient-centered, evidence-based intervention
bundle in real-time using transactional electronic health record data to improve adherence to prescribed VTE
prophylaxis for hospitalized patients. The goal of this intervention was to empower patients to make informed
decisions about their VTE preventive care and improve VTE prophylaxis medication adherence in hospitalized
patients in heterogeneous environments. Our research study showed significant improvement, with a 40%
decline of nonadministration of pharmacologic VTE prophylaxis doses, and a 50% reduction in patient refusal.
We further tested this intervention in a real-world setting where charge nurses on 8 different floors were given
the patient education bundle to deliver; nonadherence decreased 47% and patient refusal decreased by 57%.
We will scale up our intervention across diverse hospital settings, including a major academic medical
centers and two community hospitals. Between these hospitals, VTE medication nonadherence ranges from
8.8% to 17.8%. We will deliver interactive, online, scenario-based education to frontline nurses regarding the
importance of VTE prevention for hospitalized patients and will engage hospitalized patients who are at highest
risk of VTE prophylaxis medication nonadherence using a patient-centered education intervention bundle. Our
primary outcome is the proportion of administered VTE prophylaxis medication doses. Our secondary
outcomes include the incidence of patient refusal for VTE prophylaxis medication, incidence of hospital-
associated VTE using the validated AHRQ Patient Safety Indicator-12, and the proportion of patients with VTE
who miss doses of prescribed prophylaxis.
Successful completion of the proposed research will empower patients to make informed decisions about
their VTE preventive care, increase VTE prophylaxis medication adherence, and improve delivery of patient-
centered, defect-free VTE prevention to hospitalized patients across heterogeneous clinical settings.

Public health relevance
Narrative Interventions to decrease venous thromboembolism (VTE), a leading cause of preventable harm, have focused on improving prescription of prophylaxis for hospitalized patients; however, VTE prophylaxis medication nonadherence is an enormous and largely unrecognized problem in hospitals across the country. We will deliver interactive, online, scenario-based education to all frontline nurses at our participating hospitals (SA1) regarding the importance of VTE prevention for hospitalized patients. We will scale up a successful patient- centered, evidence-based education bundle intervention using real-time electronic health record data for hospitalized patients who missed doses of VTE prophylaxis medication (SA2) and assess satisfaction about the quality of nurse-patient communication regarding prescribed medication (SA3). The goal of this project is to empower patients to make informed evidence-based decisions about their VTE preventive care and improve VTE prophylaxis medication adherence among patients hospitalized in heterogeneous environments.